Detroit Cardiovascular Training Program

Project Summary
Cardiovascular disease is a leading cause of mortality in the United States and worldwide.
Understanding the biology, physiology and pathology of the heart and circulation is the foundation for
improving treatment and prevention. Wayne State University has outstanding track records in providing
extensive training in cardiovascular sciences, contributing a major role in research education in the region.
This proposal is the first competitive renew of a predoctoral training program launched in 2014. We shall
continue multidisciplinary and collaborative training effort in the education of a new generation of scientists
who will pursue a career in cardiovascular research to improve healthcare and contribute to economic
growth by innovations that can translate into medical practice.
To provide rigorous formal research training, our program focuses on supporting predoctoral graduate
students. Based on a team of 19 training faculty in 4 colleges at Wayne State University with broad
and complementary scientific expertise in cardiovascular biology and diseases under continued
directorship of Dr. J.-P. Jin, the Detroit Cardiovascular Training Program emphasizes preparing junior
scientists with strong backgrounds in molecular mechanisms of cardiovascular health and diseases using
integrative and translational approaches to scientific investigation. This continuation proposal plans to
support 6 pre-doctoral training positions. Trainees will be selected from a high-quality pool of
candidates, including under-represented minorities who may come from several institutional programs such
as the NIH Initiative for Maximizing Student Diversity (IMSD) program operated via the Department of
Physiology.
Our training faculty have strong externally funded research programs, excellent training productivity,
and multiple joint research and training collaborations. This broad and collaborative research and learning
environment enables us to provide multidisciplinary training in cardiovascular science through a
combination of didactic courses and mentored laboratory research in areas such as cardiac muscle
contractility, cardiomyopathy, heart failure, myocardial metabolism, hypertension, vascular biology, and
cardiovascular regulation and adaptation. The training also includes comprehensive instruction in the
responsible conduct of research and exploration of diverse career development as well as writing and
presentation skills for effective publications and competitive fellowship and research grant applications.
Operation of the training program will be monitored by an Advisory Committee and in consultation with
external advisors. Exceptional institutional commitments including dedicated financial support will
continue to support our program, including full scholarship support for entering PhD students in multiple
departmental programs prior to joining the T32 training. The Department of Physiology office will absorb the
personnel and accounting management cost of this university-wide training program.

Public health relevance
Project Narrative Cardiovascular diseases are leading causes of deaths in the United States. The Detroit Cardiovascular Training Program at Wayne State University is a unique NIH/NHLBI program in the region to provide predoctoral graduate students with integrative research training in basic and translational cardiovascular science. This training effort will contribute in significant ways to the education of a new generation of scientists who will pursue biomedical research to improve healthcare and make medical innovations in Detroit and in the nation.